ER calcium handling, single cell processing, and neural circuit function in vivo

Summary
Calcium is a critical second messenger in neurons, regulating neuronal processes from dendritic integration to
synaptic transmission. The endoplasmic reticulum (ER) is the major intracellular calcium store in neurons, and
aberrant ER calcium signaling is associated with many neurodegenerative disorders. However, it is unclear
how ER calcium signaling regulates neuronal function and neural circuit stability. We aim to directly interrogate
the link between ER calcium handling, single cell processing, and neural circuit function in vivo. To that end,
we will take an imaging approach to simultaneously measure and manipulate physiological neuronal signals
and ER calcium dynamics in the context of motion vision circuits in Drosophila. This versatile experimental
system provides us with unique access to fundamental, understudied biological questions about the
relationship between the ER and neuronal activity. First, the neurons that comprise Drosophila motion vision
circuits exhibit a remarkable array of cytosolic calcium signals, reflecting their computational diversity. Our
experimental system will allow us to investigate how calcium handling by the ER contributes to these diverse
cytosolic calcium signals by comparing cytosolic and ER calcium signals across well-defined neuronal cell
types in vivo. Second, neurons are extremely energetically demanding. We will leverage our in vivo imaging
system to investigate the hypothesis that stimulus-evoked ER calcium signals allow neurons to upregulate ATP
production in order to keep up with fluctuating energetic demands. Finally, tight control of cytosolic calcium
concentration is critical for neuronal functions—including dendritic integration, synaptic plasticity, and
neurotransmitter release—that control neural circuit activity and, ultimately, animal behavior. By conducting our
experiments in neurons that perform specific computations critical for the function of well-defined motion vision
circuits, we will be able to assess the consequences of ER manipulations not only on single cell processing,
but also on large-scale neural circuit function and animal behavior. Altogether, we seek to integrate information
across organizational scales—from molecules to neurons to neural circuits—to provide a mechanistic,
molecular and cellular framework for understanding how ER calcium handling contributes to brain function and
dysfunction.

Public health relevance
Public Health Relevancy Statement Aberrant calcium handling by the neuron’s major intracellular calcium store, the endoplasmic reticulum (ER), is associated with a host of neurodegenerative disorders, but it is unclear how ER calcium signaling regulates the function and stability of neurons in vivo. The mechanisms linking ER calcium handling to neuronal function are likely to be deeply conversed. By investigating the role of the ER in neuronal calcium signaling in the context of well-defined neural circuits in a tractable experimental system—the Drosophila visual system—we seek to provide an essential mechanistic framework for understanding how ER calcium uptake and release contribute to brain function in health and disease.